The role of microtubule allostery and mimicry in the regulation of tubulin post-translational modifications

ABSTRACT
Microtubules, assembled from αβ-tubulin dimers, play pivotal roles in various cellular processes ranging from
cell migration to cell division. The functionality of microtubules is diversified through post-translational
modifications (PTMs) that are “written” onto the C-terminal tails (CTTs) of tubulin. PTMs on tubulin CTTs affect
microtubule function by altering the on-rate of microtubule-associated proteins (MAPs) to the microtubule lattice.
Despite the widespread acceptance of this “Tubulin Code” theory, the mechanisms by which microtubules are
selected for modification remain poorly understood. This proposal will fill this gap using biosensors we have
developed that allow real-time visualization of microtubule PTMs both in vitro and in cells.
Our preliminary data
have revealed that one microtubule PTM, detyrosination, occurs on MTs that are in a GTP-bound, or “expanded”,
state; GDP-bound, or “compacted” MTs are remain tyrosinated. These data have led us to hypothesize that the
α-tubulin CTT (αCTT) on microtubules switches between a docked state on compacted MTs and an undocked
state on expanded microtubules. In this model, the accessibility of the αCTT to PTM writers and/or αCTT-binding
MAPs is regulated by the conformational state of the microtubule lattice. We will test the significance of this
concept in Aim 1. In Aim 2, we will investigate a second mechanism that may regulate “undocking” of αCTTs.
We propose that a subset of MAPs contain αCTT-mimicking motifs that compete for the αCTT docking site on
the microtubule surface, thereby keeping αCTTs undocked. Collectively, our project aims to deepen our
understanding of microtubule PTMs and potentially reshape the Tubulin Code theory by adding αCTT
accessibility as another layer of regulation. This work will place tubulin in line with other GTP-binding proteins
that act as molecular switches by representing the GTP-bound/expanded lattice conformation and the GDP-
bound/compacted lattice conformation as the “on” and “off” states for the MAP binding and PTM writing, which
in turn regulates the fate of cellular microtubules.

Public health relevance
PROJECT NARRATIVE Microtubules are dynamic polymers that contribute to a myriad of fundamental processes. The ability of microtubules to carry out diverse roles is thought to be modulated by microtubule post-translational modifications (PTMs), which alter their interaction with a variety of microtubule-associated proteins (MAPs). Using innovative biosensors for both microtubule PTMs and allosteric states of the microtubule lattice, this proposal aims to investigate the selective nature of specific microtubule PTMs and how these PTMs regulate interactions between microtubules and MAPs, creating “on-off” switches that regulate cellular processes.